Addressing emotional distress in dyads of persons with a Young Onset Dementia (YOD) and their care-partners

PROJECT SUMMARY:
A diagnosis of Young Onset Dementia (YOD) is emotionally difficult and often delayed because these conditions are
uncommon and many patients exhibit early symptoms atypical for dementia (e.g., personality changes, reduced motivation
and challenging behaviors). The emotional distress of the diagnosis process is amplified after a diagnosis is made due to
role changes, relational conflict, poor prognosis, and lack of impactful treatments. If untreated this early emotional distress
becomes chronic and impairs patients’ and care-partners’ ability to work together to plan for the considerable adjustments
required as the patient experiences loses to independence, function and roles in the prime of their lives. With a supplement
to R21 NR01797902, we developed and established the feasibility of Resilient Together-YOD (RT-YOD), the first dyadic
(patient and care-partner together) resiliency program for patients with YODs and their care-partners. RT-YOD draws on
mechanisms from the dyadic program “Recovering Together,” an NIH funded, feasible, well-accepted program associated
with sustained improvement in emotional distress among dyads after acute brain injury. We now propose to conduct a single
blind, virtual RCT (NIH stage 2) of RT-YOD versus a Health Enhancement Program control (HEP; N=194 dyads), to
establish the efficacy and durability (3 months) of RT-YOD on emotional distress (primary outcome) and quality of life.
We will also examine whether improvements occur through putative mechanisms and are moderated by relevant clinical
and demographic factors. Our team is uniquely positioned to conduct this study with MPIs (Vranceanu, psychologist;
Dickerson, neurologist; Syme, early stage geropsychology investigator) with prior collaboration on R21NR017979-02S1,
complementary expertise and established infrastructure to allow for timely recruitment of dyads.

Public health relevance
PROJECT NARRATIVE: A diagnosis of young onset dementia is emotionally difficult for both patients and family care-partners, often leading to chronic emotional distress that impacts quality of life for the entire family structure. Psychosocial interventions for patients with these dementias do not account for the patient-care-partner interactions, are not aimed at improving both patient and care-partner emotional outcomes, do not address interpersonal processes and the unique needs of this population, and are rarely delivered early after the diagnosis. Resilient Together is the first virtual, dyadic program that teaches resiliency and interpersonal communication skills to patients with young onset dementia and their spousal care-partners early after the diagnosis and has the potential to dramatically improve quality of life in both members of the dyad.